Cytomegalovirus Immune Responses in Chronic Lung Allograft Dysfunction Pathogenesis

While veterans are at increased risk for end-stage lung diseases necessitating lung transplantation, survival after
lung transplantation is limited by chronic lung allograft dysfunction (CLAD), a syndrome of declining lung function
post-transplant. Cytomegalovirus (CMV) is common in the US population and a major risk factor for CLAD and
death following lung transplantation. Clinically available CMV immune response assays have limited utility in
predicting CMV reactivation risk, and despite recently available new therapies, we lack an understanding of how
to manage CMV to prevent CLAD. While immune responses to CMV are heterogenous, emerging technologies
now make it possible to separate protective and maladaptive CMV-specific immune responses. Preliminary data
in this proposal distinguish such CMV-associated immune response patterns with differential associations with
CLAD, including graft NKG2C+ NK cells that potentiate CLAD risk and CD57+ KLRG1+ TEMRA, a subset of
highly differentiated CD8+ T cells, that are associated with improved outcomes. We also identified novel CMV-
associated bronchoalveolar lavage (BAL) macrophage subsets and peripheral blood epigenetic signatures that
capture previously uninvestigated CMV-specific immune subsets. Building on these novel tools, this proposal
tests the overall hypothesis that CMV-specific immune responses differentially impact CLAD risk across the life
of the allograft. Aim 1 examines whether primary graft dysfunction (PGD) potentiates maladaptive CMV-specific
immune responses. In a prospectively enrolled cohort, we well quantify our novel CMV-specific subsets in
peripheral blood and BAL fluid to determine how early graft complications shape the interactions between CMV
and graft rejection. Aim 2 will assess CMV-specific immune response subtypes in the airway at the time of CLAD
onset. Using already collected airway brush samples, we will quantify CMV-specific immune phenotypes in the
airways at time of allograft damage to dissect protective and maladaptive responses. Finally, in Aim 3, we will
use previously collected explant tissue taken at the time of re-transplantation for CLAD to determine which CLAD
pathologies co-localize with CMV-specific immune responses and how CMV may drive parenchymal cell
compositional changes. Together, these aims will provide a comprehensive understanding of CMV-specific
immune responses across the life of the allograft. These aims will leverage novel techniques in epigenetic, single
cell, and spatial transcriptional profiling using bronchoalveolar lavage, airway brushing, and explant tissue. The
feasibility of these aims is supported by established workflows for prospective recipient enrollment in Aim 1 and
already collected biorepository samples for Aims 2 & 3, with demonstrated expertise in the proposed approaches.
Differentiation of protective and maladaptive CMV-specific immune responses is a critical step in refining CMV
prophylaxis and management to improve lung transplant outcomes and would drive a paradigmatic shift in clinical
management. Broad implications of these findings may extend to acute respiratory distress syndrome, fibrotic
and inflammatory interstitial lung diseases, and constrictive bronchiolitis, which all share pathologic features with
lung transplant rejection pathology, while insights into CMV management extend to HIV, and other transplant
settings where CMV impacts veteran health.

Public health relevance
Veterans are more likely to get serious lung diseases that sometimes require lung transplant. However, the new lungs often stop working within a few years, which can be lethal. A virus called cytomegalovirus (CMV), which many people have, makes this problem worse. Building on recent technical advances, this proposal will determine which immune responses to CMV are protective or harmful and how these associations change as time goes on after the transplant. This research uses innovative techniques, such as less invasive and lower risk approaches to obtain cells from the graft, and new tools to measure gene expression in specific cells and locations. Differentiating between helpful and harmful CMV responses is crucial for improving lung transplant success, and the insights might apply to other lung conditions and transplanted organs.